Mentoring Translational Cancer Research in Oklahoma

Cancer represents a major health burden in the US. Ultimately, alleviating the burden of cancer will come from
research: the generation of new ideas, new approaches, and consequently, the development of novel
therapeutic agents. A COBRE grant will allow the Stephenson Cancer Center of the University of Oklahoma
(SCC) to provide promising junior investigators (PJIs) a focused mentoring experience to help them mature
into independently funded investigators contributing to the overall fight against cancer. Phase 1 of this COBRE
has proven to be successful in graduating 2 PJIs and establishing three successful research cores. The
Administrative and Mentoring Core of Phase 2 COBRE will be responsible for all fiscal activities related to the
COBRE program, including the placement of all orders and providing financial reports to the module directors
and investigators. Dr. Dhanasekaran will direct the Administrative Core whereas he will manage the Mentoring
Core along with Dr. Priyabrata Mukherjee. The administrative core will provide all administrative functions of
the COBRE program. Dr. Dhanasekaran will be assisted by a COBRE Coordinator and a Staff Assistant. The
Center coordinator, Ms. Mary Glover, will oversee the activities of an Administrative Assistant, Ms. Alisha
Williams. Ms. Glover has been with the Phase I COBRE from the beginning and is very conversant with the
fiscal and grant management policies of COBRE and federal funding agencies including NIH. Ms. Glover will
meet monthly with each investigator to review their accounts and mentor them in the fiscal management of
sponsored research grants. Salaries for the PI, administrative staff, mentoring faculty, core directors will be
paid through this core module. In addition, this core will administer the fiscal accounting for the proposed pilot
projects. Coordinating meetings, travel and activities of the Internal Advisory Committee and the External
Advisory Committee will be the responsibility of the Administrative Assistant, Ms. Williams, under the direction
of the PI.